Mechanisms of cyclical degeneration and regeneration in an avian model system

PROJECT SUMMARY
A central goal of regenerative medicine is to understand how cells functionally integrate into existing tissues to
restore homeostasis and behavior. Studies of regeneration following tissue damage in a group of ~6 species
have made considerable advances towards this goal by uncovering mechanisms that promote proliferation,
fate specification, and new cell survival. Pursuing these mechanisms, however, has revealed an underlying
problem: how tissue re-patterning is limited to provide functional restoration and the re-establishment of
homeostasis without detrimental overgrowth. To understand how growth and patterning are limited, and
conversely, how tissues regress controllably will require broadening the systems in which these phenomena
are examined to include models of natural, cyclical and highly stereotyped re-growth and degeneration. One
such system – seasonally breeding songbirds – offers an outstanding opportunity to test mechanistic hypoth-
eses of growth and degeneration and how events and outcomes at molecular and cellular levels impact higher-
level anatomy and behavior. This lab makes use of two different songbird species: Gambel’s white-crowned
sparrow (Zonotrichia leugophrys gambelli) and the domesticated canary (Serinus canaria domestica). White-
crowned sparrows are advantageous in having dramatic cycles of seasonal degeneration and regeneration of
the neural circuit that controls singing behavior; an extensive literature detailing their natural history; and high
tractability for experimental analyses due to their natural abundance and robustness in the lab. Canary breeds,
each having unique singing abilities and well-documented genetics, promise the ability to link historical
selection for particular allelic variants to regenerative form and function, and plasticity at the level of individuals
and populations. Exploiting the natural and dramatic degeneration–regeneration cycles in sparrows this
proposal aims to determine how cell death: (i) influences generation of new cells to limit total growth of neural
tissue and (ii) is finely tuned to prevent excessive degeneration of tissue and behavior while maintaining
competency for a return to homeostasis and subsequent plasticity. Exploiting the tight genetic control imposed
by breeders in selecting for exaggerated singing in canaries, the work aims to determine how diversification of
behavior arose from modifications to the balance between degeneration and regeneration, and how genetic
changes translate to cellular plasticity and emergence of novel behavior. Towards these goals, this program
will use a highly integrative and complementary set of approaches – including pharmacological manipulations
of intact neural circuits in freely behaving birds; classic cellular, molecular, and histological analyses; and state-
of-the-art genomic approaches – to interrogate the cellular, molecular, and evolutionary mechanisms regulating
tissue patterning and homeostasis. Uncovering proximate and ultimate mechanisms underlying tissue
remodeling will add foundational knowledge to our understanding of hypertrophy and degenerative diseases
and may reveal new ways by which lost or damaged tissues can be replaced in a clinical context.

Public health relevance
PROJECT NARRATIVE The proposed research will tackle a challenge central to public health: understanding the essential cellular and molecular mechanisms controlling tissue degeneration, regeneration and return to homeostasis in vertebrates. Using a model system that provides natural and cyclical tissue degeneration and regeneration, these efforts will investigate mechanisms underlying fundamental problems in tissue patterning and homeostasis, as well provide insight into pathological states of hypertrophy and degenerative disease and repairing lost or damaged tissue through regenerative medicine.